Dynamic Role of Hyaluronan in Ventricular Remodeling

Project Abstract
The extracellular matrix (ECM) provides structural and functional support for the myocardium; however, heart
failure alters the composition of the ECM. The ECM is composed of a number of proteins, lipids, and saccharides,
yet their function is largely unknown. We found that one of the most abundant components of the ECM,
hyaluronan (HA), accumulates following myocardial infarction; however, the role of HA following during infarct-
induced heart failure is not known. Fibroblasts are a major cell type involved in ventricular remodeling. Once
activated, fibroblasts proliferate and produce ECM components, such as collagen and HA. These events are
associated with acute scar formation and chronic ventricular remodeling. In this project, I will explore the extent
to which fibroblast-derived HA impacts the extracellular matrix. Specifically, I will study fibroblasts collagen
secretion when HA metabolism is manipulated. Additionally, I will examine the extent to which fibroblast-derived
HA contributes to acute scar formation post-MI. Finally, I will determine the extent to which fibroblast-derived
hyaluronan contributes to chronic ventricular remodeling. We contend that acute increases in HA accumulation
are required for scar formation following acute MI; however, the persistent, excessive production of HA provokes
fibrosis beyond the initial scar. Hence, we predict that HA has a dynamic role following infarct-induced heart
failure: beneficial early and maladaptive late. Taken together, these studies will provide novel insight into the role
of HA in collagen secretion, acure scar formation, and chronic fibrosis. With this fundamental knowledge, we
can, in future studies, explore therapeutic approaches. Regardless of the specific findings of this research plan,
this fellowship will serve as an excellent vehicle to enhance my training so I can eventually become an
independent scientist leading my own research laboratory. The combination of the experimental plan,
experimental tools, my sponsor, the environment, advanced coursework, and professional development
opportunities creates a high likelihood for me to realize my eventual goals and contribute significantly to the
literature in the process.

Public health relevance
Project Narrative Hyaluronan is a key component of organs and may play a role in wound healing; however, the role of hyaluronan in the failing heart is not known. By understanding the role hyaluronan plays in cardiac scar formation and chronic fibrosis, we can expose novel therapeutic approaches to optimize these adaptations and minimize disease risk. This project will employ several innovative ideas and techniques to study impact of hyaluronan on fibroblast function and ventricular remodeling.